Divergent Functions of ERK Substrate Binding Domains in Pathogenesis of Myeloproliferative Neoplasms

PROJECT SUMMARY/ABSTRACT
The Ras/MAPK pathway is activated in 85% of human cancer. Nevertheless, attempts to target Ras/MAPK
signaling have produced only limited efficacy. We hypothesize that one reason for the failure to successfully
target this pathway is that the targeting efforts have focused on the active sites of kinases in this cascade, which
has failed to provide long-lasting benefit. We hypothesize that the failure of this approach results from two
causes: 1) Active site inhibitors, which resemble adenosine triphosphate (ATP), must overcome the exceedingly
high cytosolic ATP levels in cancer cells; and 2) critical kinases in this cascade (e.g., ERK1/2) have distinct
substrate interactions domains that can perform antagonistic roles in regulating cancer progression.
Consequently, active-site focused inhibition is akin to simultaneous depression of the accelerator and brake
pedals of an automobile. We hypothesize that a more successful approach will be to develop inhibitors which
preserve kinase activity, but divert it exclusively to “brake pedal” substrates. In support, we have demonstrated
that the two substrate binding domains of ERK2, termed the D and DPB domains, play opposing roles in the
pathogenesis of JAK2-kinase driven myeloproliferative neoplasms (MPN). Indeed, the DBP and D domains act
like brake and accelerator pedals, opposing and promoting disease progression, respectively. Consequently,
pharmacologic attenuation of the accelerator pedal (D-domain) or its substrates should impair tumor progression
more potently than active site inhibition, because it selectively interferes with the disease promoting activity of
ERK2, while preserving the tumor suppressive function of the DBP-domain. While we have compelling evidence
for the opposing roles of the ERK2-D and DBP domains, the molecular basis for their action remains unclear
and this is an impediment to developing effective, pharmacologic interventions focused on the ERK2 D domain.
We now seek to address this gap in knowledge according to the following aims. We will: 1) Assess the generality
of the opposing functions of the ERK2-D and DBP domains in the pathogenesis of distinct MPN subtypes; 2)
Understand the mechanistic basis by which the ERK2-D and DBP domains exert their distinct functions; and 3)
Assess the efficacy of pharmacologic targeting of the ERK2-D domain and/or its targets in inhibiting cancer
progression. Through these efforts we expect to bring new insights into the role of ERK2 substrate binding
modules in regulating cancer progression and how to exploit this information therapeutically. While we begin with
MPN, these findings may have far reaching implications for other Ras/MAPK driven cancers.

Public health relevance
PROJECT NARRATIVE – HEALTH RELEVANCE Gaining insight into the molecular basis for the opposing roles that the ERK2-DBP and D domains play in MPN pathogenesis will enable us to exploit this information to develop new strategies for therapeutic intervention. Moreover, because the Ras/MAPK cascade is a critical driver in most human cancers, these findings will have critical implications for the treatment of many cancers in addition to MPN.